DEVELOPMENT OF A TREATMENT FOR MULTIDRUG RESISTANT GRAM NEGATIVE URINARY TRACT INFECTIONS

To support the advanced development of a promising candidate therapeutic for NIAID Category A, B, and C Priority Pathogens or emerging infectious diseases. The research and development activities to be supported will allow the candidate therapeutic product to progress through the product development pathway, and include preclinical and IND enabling development activities, chemistry optimization/development, GMP manufacturing, and clinical safety and efficacy assessment.